Influence of Task Complexity and Sensory Feedback on Cortical Control of Grasp Force

ABSTRACT
Humans can skillfully control their grasp during actions as complex and dynamic as swinging a tennis racket,
and as simple and static as holding a briefcase. Both tasks require the use of sensory feedback to achieve
and maintain an appropriate grasp force. There is evidence that motor and somatosensory cortices
communicate task-relevant information in order to enable skillful movement. Our primary goal is to uncover the
motor cortical dynamics underlying grasp force control and determine the extent to which these dynamics are
mediated by behavioral context and corticocortical communication of somatosensory feedback.
We propose to study the cortical control of grasp by leveraging the unique experimental paradigms afforded by
a bidirectional human brain-computer interface study in which participants with tetraplegia have intracortical
electrode arrays implanted in motor and somatosensory cortex. Previous work, primarily focused on reaching
movements, has demonstrated that motor cortex exhibits population dynamics that are constrained within low-
dimensional manifold. We have identified similar dynamic responses within human motor cortex that contain
information about grasp force. However, these responses are task-dependent and can change as the
complexity of the proximal arm movement changes. Here we will extend that work to study the context-
dependence of M1 dynamics across a range of static and dynamic hand and arm movements including both
overt and covert (i.e., imagined) behaviors.
Sophisticated motor control relies on sensory information to shape neural control signals emanating from motor
cortex, yet very little is known about the flow of information from somatosensory to motor cortex for the control
of the hand. We aim to quantify the corticocortical communication pathways across a range of task contexts
through the analysis of simultaneous neural recordings in motor and somatosensory cortex. We will then use
intracortical microstimulation to probe these communication pathways while providing task-relevant sensory
feedback as well as task-irrelevant stimulation as a control. Finally, we will use a brain-computer interface to
test whether there is the potential for plasticity within the corticocortical communication circuits, or whether
communication is constrained by between-area dynamics. Successful completion of this proposal will lead to
new knowledge about the role of M1 in dynamic and static grasp behaviors. We will quantify how
somatosensory input is communicated with M1 and whether corticocortical communication pathways can be
modified through training, which has relevance to understanding skill learning and improving rehabilitation.

Public health relevance
PROJECT NARRATIVE Humans can perform a range of static and dynamic grasping movements with a high level of skill, yet it is unclear how cortex achieves this flexibility in control. We will study how population dynamics in motor cortex change with behavioral context and how they are shaped by sensory feedback. Through this proposal, we will gain a better understanding of how motor cortical activity generalizes across static and dynamic behaviors as well as the potential to drive plasticity within cortical circuits that communicate sensorimotor information, which has relevance for understanding skill learning and improving rehabilitation after injury.